Molecular Modeling of the DR domain of an HIV restriction factor PSGL-1

Project Summary/Abstract
Studying the anti-HIV mechanisms of restriction factors is central to understanding virus-host
interaction and for developing novel therapeutics. Recently, PI Wu's lab has co-identified a new
HIV restriction factor, PSGL-1 (P-selectin glycoprotein ligand-1), that inactivates the infectivity
of HIV virions released from HIV producing cells. Wu and his collaborators have further
demonstrated that PSGL-1 acts through a novel mechanism of virion incorporation of PSGL-1
that sterically hinders particle attachment to target cells. PSGL-1 is a dimeric mucin-like 120-KD
glycoprotein that is primarily expressed on the surface of lymphoid and myeloid cells, and
binds to P-, L-, and E-selectins for leukocyte rolling and transmigration. Structurally, PSGL-1
has a relatively rigid and elongated extracellular domain that extends nearly 60 nm from cell
surface. A large structural part of the extracellular domain also consists of 14-16 tandem
decameric repeats (DR), which are characterized by repeated stretches of 10 amino acids with
numerous O-glycosylated threonines (30%) and prolines (10%). Our preliminary studies
discovered that DR plays a pivotal role in PSGL-1's anti-HIV activity, and a single DR possesses
basic anti-viral activity. Nevertheless, individual DR shows amino acid sequence variation and
varying degrees of anti-viral activity. We hypothesize that the structural rigidity and
glycosylation of DR affect its anti-HIV activity. The proposed research integrates molecular
dynamics simulations, machine learning, and laboratory experiments to study the anti-HIV
properties of DR. The proposal has two aims. Aim 1 is to determine the structure-function
relationship of DR via the integration of In silico molecular modeling, DNA mutagenesis, and
functional anti-HIV assays. We will apply all-atom replica exchange with solute tempering
(REST) molecular dynamics simulations to examine DR glycosylation, rigidity, and extension.
We will also apply machine learning to feature datasets extracted from molecular simulation of
DR variants. We expect that the integration of our studies from molecular modeling, DR
mutagenesis, and functional anti-HIV assays will guide the design of novel PSGL-1 variants
with greater anti-HIV activity. Aim 2 is to test and validate the anti-HIV activity of PSGL-1 in
vivo in a humanized mouse model for control of HIV replication in the absence of ART. The
proposed work will identify how DR residue positioning and composition quantitatively
correlate with PSGL-1's anti-HIV function. Our study will also help developing novel
therapeutics, based on PSGL-1's anti-HIV activity, for a functional cure of HIV infection.

Public health relevance
This proposed study integrates molecular simulations, artificial intelligence, functional anti-HIV assays, and animal models to explore the anti-HIV properties of a host protein PSGL-1. The study will provide new knowledge fundamental to understand PSGL-1's anti-HIV activity, and could offer new therapeutics for a functional cure of HIV infection.